Merging bacteriophage biology with microbial glycobiology

PROJECT SUMMARY
Bacteriophages, or phages, are considered the most abundant organisms on Earth with an estimated 10+31
particles in the biosphere. These viruses are in a perpetual arms race with bacteria and arguably the major force
driving bacterial evolution. Similarly, phages continue to develop novel mechanisms to infect their host and avoid
detection, and carbohydrates are central to all these processes. As a microbial glycobiologist, my research
originally focused on understanding the mechanisms behind bacterial glycoconjugate biosynthesis where we
discovered that bacteria are capable of N-glycosylating proteins and campylobacters synthesize capsules rather
than repetitive lipopolysaccharides. These studies evolved into better understanding the selective pressures that
promote selection for glycoconjugate variants and discovering that a single strain of C. jejuni can express over
1000 different capsule structures and many of these variations can be observed when combining the strain with
different phages. Our curiosity has now expanded toward understanding the importance of other glycostructures
involved in phage-host interactions beyond C. jejuni and beyond surface polysaccharides.
Using the knowledge we gained in studying microbial glycoconjugate synthesis and phage-host
interactions over the last two decades, current studies will focus on exciting new discoveries describing
other phage glycosylated macromolecules.
1) We are eager to explore the two mechanisms used by C. jejuni phages to replace canonical DNA bases with
non-canonical bases with 100% efficiency. This will involve investigating the activity of a new
deoxyribosyltranferase and how it couples to a transglycosyltransferase that efficiently removes nucleobases
post-replicatively. CryoEM structures of this transglycosyltranferase in comparison with less efficient enzymes
will not only help us to understand the transfer mechanism, but can also lead to the development of new
biotechnological tools for nucleic acid biosynthesis and vaccine development.
2) Recently a set of glycosyltransferases (GTs) responsible for glycan addition to capsids and tail tubes of phages
infecting Mycobacterium species were identified, but these modifications showed no benefit to phage infectivity.
We hypothesize that these GTs could also modify host proteins, including phage receptors that subsequently
prevent phage superinfection. We propose to use our methods in recombinant bacterial glycoengineering as well
as GT expression in the native host to better understand the impact of phage GT expression on the microbe as
well as expand the toolbox of novel characterized enzymes available for therapeutic development.
3) All cystoviruses isolated to date infect Pseudomonas species, but we recently isolated an enveloped virus
infecting a multidrug resistant strain of Acinetobacter radioresistens. These viruses enclose themselves with
bacterial inner membranes that also contain glycoconjugate biosynthetic machinery. We aim to verify their
composition and better understand their biogenesis for possible use as maleable self-assembling nanoparticles.

Public health relevance
NARRATIVE Bacteria are under constant attack by their own viruses, known as bacteriophages, or phages. Carbohydrates are key components of nucleic acids, glycoproteins and glycolipids in all domains of life and thus play a major role in this perpetual battle between bacteria and phages as the two evolve to outcompete each other. This proposal examines two general approaches phages are using to win this battle: 1) through modifying their genetic code to prevent host recognition and cleavage, and 2) by hampering with the host’s glycosylation machinery for benefits that are still not understood, but unraveling these processes can lead to the identification of new biotechnological tools or therapies against multidrug resistant pathogens.